PROGRAM LEADERS--CANCER BIOLOGY

The Cancer Biology (CB) Research Program is composed of 46 Research Members and 25 Members from 15 basic science and clinical departments at Baylor College of Medicine. The Program members perform basic research in a diverse array of cancer and cancer-related research projects. The Cancer Biology Program has three major themes: (1) Human cancer pathways, (2) Mouse models of Cancer, and (3) Cancer Genomics and Bioinformatics. The vast majority of Research Members of the Program are principal investigators on NIH-funded grants. The program had a total of $4,610,725 support from the NCI last year and overall received $12,247,835 in peer-reviewed funding. Since being rated as an excellent to outstanding program in the initial review, the Cancer Biology Program has worked to build on its strengths of scientific productivity and a strong cadre of mouse cancer model specialists. In addition, the Program has increased the number of intra-programmatic and inter-programmatic collaborations as evidenced in its members publication record over the last three years. Approximately 300 cancer-related publications have been published by Research Members from 2006-2009 and 15% of these publications are intra-programmatic and 29% are inter-programmatic in nature. Finally, to remedy a perceived early weakness, the Program has greatly enhanced its interactions with the Baylor Human Genome Sequencing Center and has organized a thematic group of cancer genomics and bioinformatics experts. The Cancer Biology Program has almost doubled its membership from the last review and collaborations and interactions have increased in part because of Program meetings, sponsored speakers, symposia, and pilot project funding initiatives. The collaborative efforts among Cancer Biology Program members was recently evidenced by the participation of seven members in The Cancer Genome Atlas multi-institutional consortium to map the genetic, epigenetic and transcriptomic alterations in glioblastomas and ovarian cancers. The Program Leader is Lawrence A Donehower, Ph.D. and the Program co-Leader is Francesco DeMayo, Ph.D.

Public health relevance
Scientists in the Cancer Biology Program of the Dan L. Duncan Cancer Center perform research on changes in cellular processes that cause a normal cell to become a cancer cell. Understanding these basic changes will facilitate the development of more effective cancer therapies.